Elucidating Reward Network Modulation in Medial Forebrain Bundle Deep Brain Stimulation for Treatment Resistant Depression

Project Summary
Treatment resistant depression (TRD), representing up to 30% of major depression diagnoses, is an
incapacitating disability affecting millions worldwide. Limited improvement with non-invasive treatments has led
to the use of deep brain stimulation (DBS) as it directly engages critical networks. Unfortunately, progress with
DBS for depression has been limited seen in the failure of two clinical trials due to a lack of understanding its
mechanism of action. This results from an incomplete knowledge of the network effects of chronic
stimulation for depression. Overcoming this barrier necessitates understanding how changes in metabolism
and functional connectivity (FC) of key mediators correlates with observed behavioral change. Within the
affective network, the ventral tegmental area (VTA) is a critical integrator of both emotional and behavioral reward
processing, which is dysfunctional in major depression and anhedonia (inability to experience reward/pleasure).
Although direct modulation of the VTA is difficult, the supero-lateral medial forebrain bundle (MFB) is a key white
matter bundle demonstrated to structurally connect the VTA through to the prefrontal/orbitofrontal cortex
(PFC/OFC). For over 10 years, we have actively pursued a clinical trial on DBS to the MFB, demonstrating a
rapid and significant improvement in anhedonia and depressive symptoms with 80% response rate at 5 years.
Lack of uniform improvement to MFB DBS in depression, however, must be corrected and points to an
incomplete understanding of network response to modulation. It is imperative that we use the results from brain
imaging at a therapeutic stimulation threshold to evaluate the mechanism of reward network modulation that
underlies an improvement in anhedonia. If such an imaging biomarker is identified, then it can be used to guide
successful programming. If anhedonic TRD patients undergo MFB DBS and a threshold of therapeutic
stimulation consistently produces key imaging findings correlated with improvement in reward processing, then
this would demonstrate an objective biomarker of reward network engagement. The overall objective is to identify
metabolic and functional imaging changes in the reward network secondary to therapeutic MFB DBS, which may
be biomarkers of reward network modulation correlated with reversal of anhedonia. Our central hypothesis is
that FC of the ventral PFC/OFC, caudate, and dorsal anterior cingulate ‘network’ is modulated by MFB
DBS in an amplitude-dependent fashion. In Aim 1, we seek to characterize the temporality of reward network
changes induced by MFB DBS using imaging collected at multiple time points pre-/post-surgery during stepwise
amplitude titration. In Aim 2, we seek to confirm that induced reward network imaging changes are reversible
during MFB DBS discontinuation and correlate with change in reward processing behavior. The proposed aims
will confirm reward network modulation by MFB DBS, and by acquiring serial imaging during stepwise amplitude
increments until a stimulation threshold is identified to incur a reversal of anhedonia, identify objective imaging
biomarkers that can predict MFB DBS-induced reward network modulation and guide successful programming.

Public health relevance
Project Narrative Treatment resistant depression (TRD), representing up to 30% of major depression diagnoses, is an incapacitating disability affecting millions worldwide. Deep brain stimulation (DBS) is a promising effective treatment strategy, however, progress has been limited due to an incomplete understanding of the reward network effects of chronic stimulation for depression. The work proposed in this study, to perform imaging to understand the evolution of induced reward network expression changes due to stepwise stimulation amplitude titration, and to correlate their change with improvement in anhedonia, will identify objective biomarkers that can be used to ultimately guide programming for optimal reward processing improvement.